Alcohol Availibility and Intimate Partner Homicide

[unreadable] DESCRIPTION (provided by applicant): The broad, long-term objectives of this proposal are to better understand the roles of alcohol availability and laws prohibiting batterers from possessing firearms in intimate partner homicide (IPH) and to increase the safety of victims of intimate partner violence. The specific aims are to: 1) determine if there is a significant association between alcohol outlet density and IPH at the city level; 2) assess the relationship between state excise taxes on beer and IPH; 3) assess the direct effect of laws prohibiting perpetrators of domestic violence from possessing firearms on IPH; and 4) assess the effects of criminal justice policies and practices regarding intimate partner violence and restraining order enforcement on IPH. Using a retrospective research design, this project will examine the impact of alcohol availability and firearm laws on IPH in forty-eight of the largest US cities from 1976 to 1996, controlling for factors known to be related to IPH. The relationships will be determined using longitudinal statistical techniques. The results of this project will provide valuable evidence for reassessing policies related to alcohol availability for the purpose of decreasing intimate partner homicide. [unreadable] [unreadable]